Data Core

DATA CORE
Summary
The overall objectives of the Data Management Core are (1) to support all aspects of data collection, verification, consolidation, and documentation for the CLDRC, (2) to facilitate cutting-edge analyses by all CLDRC investigators by providing support for investigators with less experience with specific statistical methods, and (3) to enable CLDRC investigators and other researchers in the field to take advantage of the datasets generated by the CLDRC for innovative analyses of specific learning disabilities (SLDs) and related difficulties such as attention-deficit/hyperactivity disorder (ADHD) and academic anxiety.
The collaborative structure of the CLDRC provides a unique opportunity for interdisciplinary cross-project analyses of data from both community and clinic samples, single individuals and familial relationships such as twin pairs and siblings, cross-sectional and longitudinal designs, neuropsychological and neuroimaging measures, and molecular genetic data from our own samples and from the large publicly-available databases of genotypic and phenotypic information generated by the rapidly expanding literature of genome-wide association studies (GWAS). The Core will coordinate data sharing procedures to ensure that summary data generated by the Center will be made available to qualified investigators outside the CLDRC in a timely manner to maximize the impact of the NICHD investment in the CLDRC. We will especially welcome and encourage requests to share data from early-stage investigators and scientists in settings with limited resources.